Y-SCORCH 2.0: Further Data Mining and Functional Characterization for Single Cell Opioid Responses in the Context of HIV (SCORCH) Program

Opioid use disorder (OUD) and HIV, which affect 53 million and 40 million people respectively, exhibit a
syndemic relationship due to structural social and health conditions that impact at least 20 million individuals
globally. Both conditions contribute to central nervous system (CNS) dysfunction through distinct and
synergistic pathways. Despite extensive research, the specific cellular mechanisms altered by OUD, HIV, and
their interaction remain poorly understood. A comprehensive understanding of brain cell states and their
localized responses is essential for developing targeted treatment strategies. The SCORCH initiative has
facilitated unprecedented data generation through single-nucleus interrogation of brain tissue relevant to HIV
and substance use disorders, providing an unparalleled opportunity to explore the molecular underpinnings of
HIV, OUD, and their intersection. As the first data generation project supported by the SCORCH initiative, our
Y-SCORCH program has significantly contributed to data generation and intellectual leadership. Y-SCORCH
2.0 aims to leverage our SCORCH experience and expertise to apply advanced tools to analyze transcriptomic
and epigenetic data from the SCORCH consortium and novel spatial transcriptomic data to identify treatment
targets. Y-SCORCH has already generated 346 single-nucleus transcriptomic and epigenetic datasets from the
prefrontal cortex, insular cortex, and ventral striatum, across control, HIV, OUD, and HIV+OUD conditions.
Through differential expression (DE) analysis, significant changes in immune activation and response have
been identified, revealing widespread transcriptomic changes across cell types and elucidating cellular circuits
involved in pathogenesis. The proposed research aims to mine SCORCH Consortium data to create a
comprehensive catalog of DE genes in HIV and OUD across various brain regions and cell types. This will be
achieved by applying standard protocols for DE analysis to ten brain regions and classifying DE genes in HIV
versus controls, OUD versus controls, and HIV+OUD versus OUD cohorts. The team will also use neural
network models to differentiate batch effects, intrinsic cell type representations, and disease-dependent
variations. Additionally, the study aims to utilize neural networks and machine learning models to identify
spatial signatures of HIV, OUD, and their interaction. Methods such as SIMVI (an unsupervised Variational
Autoencoder) and SORBET (a supervised graph-neural network) will be used to analyze spatial
transcriptomics data, identifying cell-cell interactions and expression gradients. The final aim is to leverage
external datasets to further characterize the DE genes catalog and elucidate underlying mechanisms and
etiology, using genome-wide association studies and other external resources. Y-SCORCH 2.0 will continue to
advance the understanding of HIV, OUD, and their synergistic effects by employing cutting-edge
methodologies, ultimately contributing to identification of therapeutic targets for these conditions.

Public health relevance
Opioid use disorder (OUD) and HIV are two widespread conditions affecting millions of people globally, often co-occurring in people due to overlapping social and health factors, and both independently and together can harm the brain and nervous system. Although researchers have extensively studied these effects using advanced techniques, the specific ways OUD and HIV alter the brain at the cellular level are still not well understood, and further research is needed to develop effective treatments. We propose to apply differential analysis and identification of spatial signatures of data already generated from brain tissue through the SCORCH Consortium in combination with brain external datasets to reveal cellular mechanisms of CNS dysfunction in these conditions to identify targets for treatment.